Fusion peptide specific B cell responses and the role of follicular T cells in accelerated antibody maturation

Project 1.
Abstract: Different regions of HIV Env have been identified as targets of broadly neutralizing
Ab activity. The maturation, magnitude and breadth of such bNAb is a critical challenge for
HIV vaccine development as the evolution of these responses to broad neutralization requires
a lengthy and complex maturation process with rounds of somatic mutations in the B-cell
follicle. This is also the case for the Fusion Peptide region in Env, which has emerged as a
promising vaccine target. Among others, vaccine immunogen persistence and dose are
considered important factors in the maturation process for bNAb, possibly linked to the need
for durable helper function provided by follicular T cells. The main hypothesis of Project 1 is
that bNAb activity early in infection, referred to here as accelerated neuralization, is dependent
on strong Tf help, which could not only be mediated by CD4+ Tfh cells but also by CD8+ Tfc.
Indeed, while envelope-specific follicular CD4+ T-helper (Tfh) have been shown to provide
help for B cell responses, concerns exist that these cells may also facilitate breakthrough
infections. For that reason, across all three projects, the inclusion of CD8+ Tfc that could
supplement or even substitute such CD4+ Tfh is a central theme. In Project 1, we will use
human samples from unique clinical trial and cohort studies, to identify Env- and FP-derived
sequence variants associated with broad neutralization and ask whether these or other targets
in Env/FP serve as targets for an effective CD4+ and/or CD8+ Tf response. Through
innovative in vitro experimentation, we will validate these in vivo observations and functionally
test whether and how these cells drive the maturation of broadly neutralizing Ab responses. A
successful outcome of our work will produce a more complete picture of the role that FP
targeting and Tf cells play in the development of effective humoral immunity to HIV and clarify
whether CD8+ Tfc are a specific subset of the total CD8+ T cell response to viral infections that
can be leveraged by vaccination. These insights would provide the base for fundamentally
new prophylactic HIV vaccine strategies that de-risk current approaches and that aim to
mobilize all possibly available follicular help and Env/FP-immunogen variants to effectively
accelerate the extraordinarily complex maturation of HIV specific B cell immunity.